Limited Competition for Continuation of the MAPP-RN DCC

Project Summary This proposal for an Administrative Supplement to the U24 grant for the Continuation of the Multidisciplinary Approach to the Study of Chronic Pelvic Pain (MAPP) Research Network Data Coordinating Core (DCC) is being submitted by the DCC for the MAPP Research Network (MAPP-RN) at the University of Pennsylvania Perelman School of Medicine. The DCC team will provide additional services beyond those currently funded as the DCC for the MAPP Research Network, in support of new Specific Aims 1-5 during the current budget year 14 (BY14). The clinical data, documentation and descriptions of the biospecimen resources from the MAPP I EPS and MAPP II SPS will be made accessible for “public facing” exploration via a re-engineered MAPP website (Specific Aim 1), together with a totally new MAPP DataView toolkit (Specific Aim 3) designed for data visualization and for the conduct of comparative analyses between, and within, the extensive EPS and SPS cohort data, as well as to conduct advanced analyses within selected subgroups assembled by aggregating aligned data across both of these two cohort studies. In addition to implementing final data curation and harmonization across the EPS and SPS cohort data, the DCC will prepare extensive documentation for simultaneous posting on the new MAPP website and for deposit to the NIDDK Repository (Specific Aim 2). Furthermore, the DCC will prepare workshop materials and host MAPP DataView workshops, promoting MAPP data use for new research investigations (Specific Aim 4). Educational materials designed for investigators and research teams to maximize the utility of these data resources and to implement specialized statistical procedures (consensus clustering for baseline subgroup discovery, quantifying clinically meaningful change utilizing Global Response Assessment (GRA) scores and levels of symptom change, longitudinal functional clustering for outcome subgroup discovery) applied to MAPP II SPS data will be emphasized. In particular, the DCC will prepare longitudinal analyses using the Global Response Assessment (GRA), Pelvic Pain Severity (PPS) and Urinary Symptoms Severity (USS) profiles available within the MAPP II SPS to identify factors associated with simultaneous improvement in both PPS and USS symptom profiles, in contrast to patients that improve only in PPS, only in USS, or in neither of PPS or USS (Specific Aim 5).

Public health relevance
PROJECT NARRATIVE In this application, the MAPP Research Network Data Coordinating Core (DCC) requests a 1-year administrative supplement to provide additional services beyond those currently funded. These services include 1) re-design and deployment of a “public facing” MAPP website; 2) close-out of data harmonized between MAPP I EPS and MAPP II SPS, including extensive documentation; 3) expansion of MAPP DataView toolkit functionality; 4) preparation and hosting of MAPP Data Use workshops; and 5) applications of advanced functional clustering methods to longitudinal symptom profile changes in Pelvic Pain Severity (PPS) and Urinary Symptom Severity (USS) simultaneously. Workshop topics and MAPP DataView functionality will be planned in collaboration with MAPP Executive Committee and NIDDK Program Staff. Page 7 Project Narrative